Temporary childbirth migration: understanding the magnitude and implications for maternal and infant health

PROJECT SUMMARY
Women in South Asia often return to their natal homes in different communities during pregnancy, for childbirth,
and postpartum. Our team conducted the first robust measurement of this phenomenon in two states of India
(coining the term “temporary childbirth migration (TCM)”) and found that about one-third of women returned to
the natal home point during the perinatal period. Given India’s reliance on community-based maternal and child
health care delivery, TCM may disrupt care continuity, negatively impacting health care access and health
outcomes. Conversely, given the lower status of women in their marital homes, TCM could potentially improve
health outcomes for migrants, leaving those “left behind” at higher health risk. A greater understanding of TCM,
its impact, and associated mechanisms are critical inputs to inform policy and practice to improve maternal and
neonatal health in India. However, despite anecdotal evidence of TCM’s widespread prevalence across diverse
Indian contexts and its potential impact on health, it is not well defined or quantified in the literature. The objective
of this study is to characterize TCM in India, describe its impact on perinatal outcomes, and explore the health
care continuity and social support as potential mediators of these relationships. First, we will collect cross-
sectional data from roughly 6000 women at eight Health and Demographic Surveillance Sites throughout India
to define and characterize temporary childbirth migration, including magnitude, timing, drivers, and
sociodemographic and geographic heterogeneity. Triadic qualitative interviews with household members in 2
sites will shed additional light on selection and drivers of TCM. Then, we will select three sites based on
geographical distribution and differing levels of TCM for a longitudinal study. We will recruit 1000 women in each
site (3000 total) who are early in pregnancy and follow them until one year postpartum, some of whom will
migrate and some not. We will collect monthly telephone surveys and five longer in-depth surveys from women
about migration patterns, health care use, maternal and child health outcomes, social support, and socio-
demographics. We will ask women to take photographs on their mobile phones (provided to those without
phones) of health record data to have higher quality maternal and infant outcome data. We will estimate the
impact of TCM on preterm birth and identify women most at risk. We will then examine disruptions in the
continuum of perinatal care and social support as potential mediators between temporary childbirth migration
and health. These findings will help us understand factors that may be contributing to poor maternal and child
health outcomes in India, and potentially other parts of South Asia and other regions. A better understanding of
the impact of TCM can help programs and policies better support women to obtain the care and support they
need in pregnancy and postpartum.

Public health relevance
PROJECT NARRATIVE Women in South Asia, including India, often migrate from their husbands’ home back to their parents’ home in pregnancy and for delivery, which may have implications for maternal and child heath, yet this phenomenon is understudied. We will conduct a multisite longitudinal study in India to understand and describe this phenomenon (which we call temporary childbirth migration) and measure its impact on infant and maternal health, with a primary outcome of preterm birth.